Coronavirus Immunoassay Core

Immunology Core Summary
The overall objective of the Immunoassay core is to provide high quality materials that will make feasible the
studies proposed in projects 1 and 2, and especially to assure that studies are using reagents and pretested
materials that will produce reliable and reproducible results. The core will provide purified recombinant viral
proteins for use in both projects and provide binding and functional immunoassays for in depth analysis of
antibody responses to SARS CoV-2 in different population groups over a period of follow-up. The core is made
up of two labs, one at Tulane and one at WSU, which will function in close collaboration to achieve our aims